ADMINISTRATIVE CORE

The Administrative Core will be responsible for the overall administration of the Program. It will provide clerical support, meeting organization, data management and planning/evaluation services to the Program. Dr. Lynda Chin (PI) and Dr. Flaherty (Co-PI) will work jointly, in a collaborative effort, to oversee the Administrative Core. Both Drs. Chin and Flaherty are highly experienced in organizing and maintaining multi-institutional, multi-investigator initiatives. Dr. Chin will primarily be responsible for administration of the academic research activities, while Dr. Flaherty will primarily administrate the clinical aspects of this Program. Importantly, this core will play an active role in coordination with other centers within the TMEN network to promote synergistic and collaborative interactions.